NEUROVIROLOGY AND NEUROIMMUNOLOGY OF SCHIZOPHRENIA

The project on neurovirology and neuroimmunology is focused on obtaining evidence that the pathogenesis of schizophrenia and other neuropsychiatric illnesses may involve either an infectious process by a viral agent and/or an autoimmune reaction involving central nervous system tissue autoantibodies.